Advancing Health Equity by Understanding the Impact of Race on PTSD Symptom Improvement Following Evidence-Based Psychotherapy

Background: In several studies, including our national VHA study examining nearly 15 years of VHA utilization
in over 300,000 Iraq and Afghanistan War Veterans who had a post-deployment PTSD diagnosis, Black
Veterans receiving evidence-based psychotherapy (EBP) demonstrated decreased odds of PTSD symptom
improvement, relative to their White counterparts.
Significance: We propose a mixed-methods study to understand these disparities, improve health service
delivery, and promote equity in PTSD EBPs, goals aligned with VHA priorities.
Innovation & Impact: Despite documented disparities in PTSD EBPs for Black Veterans, there have been no
national mixed-methods studies across the VHA to better understand these disparities with the goal of
impacting delivery of care. Given that MPIs are researchers and trained clinicians, as are several of our co-
investigators, we have the skills required to acquire information that will impact how these treatments are
delivered.
Specific Aims: Our aims are: (1) To determine factors associated with less PTSD symptom improvement for
Black Veterans receiving PTSD EBPs in the VA through analysis of electronic health records (EHRs); (2) To
determine needs, perceptions, and experiences of Black Veterans engaging in PTSD EBPs through qualitative
interviews, including the processing of race-based trauma during EBPs; and (3) To determine the perceived
efficacy of current trauma-focused treatments in supporting experiences of racial trauma though interviews with
Black Veterans.
Methodology: We will utilize a mixed methods approach to identify how to improve PTSD EBPs for Black
Veterans. The quantitative study is designed to better understand factors associated with EBP disparities in
Black Veterans by examining demographic, clinical, service utilization, and EBP factors in an all-era, national,
clinical sample (Aim 1). We will include all Veterans enrolled in the VA who have a PTSD diagnosis, have
initiated or completed an evidence-based psychotherapy, and have at least two PTSD symptom measures
during treatment. For the primary outcome of the quantitative aim, we will examine change in PTSD symptom
score from before to after PTSD EBPs. We will then determine factors, including race, that are differentially
associated with symptom improvement. The qualitative study (Aims 2 and 3) will overlap with the quantitative
study. Participant stakeholders (N=60) will include Black Veterans who have participated in VHA PTSD EBPs
from the four US regions. We will recruit Veterans to capture adequate diversity in service era, gender, and
other intersecting identities (e.g., LGBTQ+ and Veterans with disabilities), and will interview Veterans until
thematic saturation is reached for each qualitative aim. For our qualitative analysis, we will identify themes that
arise from our semi-structured interview guide using Rapid Analysis Procedures. We will use these themes to
understand potential disparities as well as how to improve PTSD EBPs for Black Veterans.
Next Steps/Implementation: We will disseminate results through publications, conferences, and our VHA
operational partners, who we will work closely with throughout the grant. Next steps, depending on our mixed
methods findings, include submitting a grant focused on applying findings from the current study to improve
administration of PTSD EBPs for race-based trauma and to train PTSD EBP providers on assessment and
treatment of race-based trauma within PTSD EBPs. We will work closely with our partners to leverage
information learned from our research to ensure health equity in PTSD EBP treatment.

Public health relevance
Prior studies indicate that Black Veterans demonstrate less PTSD symptom improvement (i.e. disparities) following PTSD EBPs, compared to White Veterans. The objective of this study is to understand these disparities in PTSD evidence-based psychotherapy (EBPs) and to improve PTSD treatment for Black Veterans. Our aims are to determine factors associated with less PTSD symptom improvement for Black Veterans receiving VA PTSD EBPs through analysis of electronic health records, and to interview all-era Black Veterans throughout the US about their needs and experiences in PTSD EBPs, especially related to addressing race-based trauma. Leveraging our team’s extensive work with VHA national data and expertise providing care for PTSD, we will work to improve PTSD care. Our goal is to close the gap in PTSD symptom improvement and advance health equity by better understanding these disparities through a mixed methods health services project, collaborating with our VHA partners to improve race-based trauma care for Veterans.